Brilliant epitopes for improved cancer vaccines

Project Summary
We propose to advance next-generation cancer vaccines with superior immunogenic payloads
for KRAS mutations, building upon the safety and proven efficacy of the mRNA-LNP platform for
vaccine delivery. The totality of results from our proposal will advance preclinical optimization of
a next-generation, lead vaccine, supporting IND submission and thoughtful advancement into
clinical trials. We will focus on KRAS mutations because of their prevalence in pancreatic cancer,
which is an indication with a poor prognosis with limited therapeutic modalities. We will
characterize the immunogenicity of our novel vaccine products and evaluate the cross-reactivity
of the T cell responses they prime that recognize tumor presented neoepitopes (Aim 1). We will
perform this work by sequencing T cell receptors in mouse models containing humanized HLA
alleles. Our approach has been enabled by the development of programmable mRNA vaccine
platforms and new computational methods.

Public health relevance
Project Narrative The human immune system provides an important defense against cancer, and when appropriately activated and combined with other therapeutics it can cure cancer in some circumstances. We are developing vaccines for pancreatic, lung, and colorectal cancer that are expected to improve the ability of the immune system to participate in cancer cures. The present work will test the ability of these improved vaccines to induce safe and powerful anti- tumor immune responses in mice that have humanized immune systems.